Portable Low-Cost Pulmonary Forced Oscillation Technique Device

Project Summary Abstract
Koronis Biomedical Technologies and its collaborators propose to commercialize a low-cost, portable
respiratory assessment device using the forced oscillation technique (FOT). The proposed FOT
device requires zero skill from the subject and operator, making it ideal for occupational health
screening, physician office use, and home monitoring. The current gold standard for accurate and
repeatable measurement of lung function is spirometry. Spirometry is a pulmonary function test that
measures the volume and rate of airflow a patient can maximally exhale into a tube attached to a
precise airflow meter. The role of spirometers has been limited due to their reliance on technique
adherence. Unlike many medical diagnostic tests where the patient is essentially a passive
participant, spirometry requires active patient participation. The procedure requires the patient to take
the deepest breath possible and then exhale as hard as possible for as long as possible. The test is
normally repeated to ensure reproducibility. Spirometry results are highly dependent on patient
cooperation and effort. Patients often face a significant learning curve. Some patients cannot, or will
not, produce interpretable results. FOT measures pulmonary airway resistance and reactance. In
contrast to traditional spirometry, the key clinical advantage of FOT is that the technique is passive
and does not require the patient to breathe forcefully on command. In this project, all components of
the production system will be finalized and evaluated for usability and performance in human
evaluations along with market release under FDA market clearance.

Public health relevance
Project Narrative Asthma and COPD are major chronic diseases that affect millions of Americans and presents an enormous burden to the healthcare system. It is well-accepted in the management of asthma that chronic monitoring for worsening inflammation of airways is important. Acute exacerbations of COPD are periodic flares of COPD that lead to worsened quality of life, hastened lung function decline, and higher risk of subsequent cardiovascular events (e.g. stroke, myocardial infarction). A low-cost lung function assessment technology that requires minimal effort to operate properly would fill an unmet need in the management of these diseases.